Post Doctoral Training Program in Alcohol Studies

The objective of this Alcohol Research Training grant is to provide specialized training for post-doctoral fellows
in alcohol research. The program is designed to focus on the etiology, neurobiology, and mechanisms of
alcohol use and misuse, and novel treatments for alcohol use disorders. It utilizes an interdisciplinary
approach, representing psychology, psychiatry, medicine, social work, public policy, epidemiology, genetics,
and neuroscience, and it draws on experienced faculty from inter-related institutions: University of Connecticut
School of Medicine (UConn Health) and University of Connecticut (UConn-Storrs). The program will benefit
from a variety of resources, including our P60 Alcohol Research Center, library services, a computer center,
courses in advanced statistical techniques and a newly funded Certificate Program in Addictions Studies,
human laboratories, an outpatient clinical research center, and the UConn Health Disparities Institute and
Health Career Opportunities Programs. Trainees will select from four Core areas in clinical and translational
research: 1) etiology and risk factors of alcohol use disorders; 2) neurobiology of alcohol use and disorders; 3)
treatment of alcohol use disorders; and 4) mechanisms of alcohol treatment or its use. Our Training Faculty
also has strong interests in multicultural and racial/ethnic minority aspects of alcohol use, HIV and other
medical and psychiatric co-morbidities, electronic health technologies, and translational research. The training
experience will emphasize these Elective research areas as well. Fellows will be assigned a primary and
secondary mentor, based on similar research interests across these core and elective areas. The primary
mentor will provide instruction in methods, design, analysis and ethics of alcohol research within the trainee's
core research area(s), and the secondary mentor will ensure the trainee is meeting program and personal
professional milestones, and when appropriate, collaborate with the trainee on writing papers for publication in
elective areas. Additionally, each fellow will establish relationships with at least one external advisor, a
prominent alcohol scholar outside the training institutions. The purposes of this connection are to extend the
fellow’s training experiences beyond the local research community and stimulate networking and career
development opportunities within the larger alcohol research field. The training program will include a
curriculum involving seminars on foundations of alcohol research, ethics, professional development and grant
writing. In conjunction with other T32s in the New England, we will hold an Alcohol Research Retreat in which
trainees will present and can meet others in their own and other career stages. Expectations will be to 1)
produce at least two first authored publications per year of training, 2) initiate and complete an independent or
collaborative research project, 3) present research at RSA and other scientific conferences, and 4) prepare a
grant application by the end of the training period. Given our successes in objectively measured standards with
recent trainees, this program is well-poised to train the next generation of alcohol researchers.

Public health relevance
RELEVANCE: Alcohol misuse is a significant public health concern. This training grant draws from multiple disciplines to prepare post-doctoral fellows to investigate biological, psychological, and social mechanisms that underlie alcohol misuse and its treatment. It sets clear and objective standards to assist fellows in pursuing a career in alcohol research, encourages professional development and networking opportunities, and emphasizes multicultural and ethnic issues related to alcohol research, as well as translational issues, mobile health technologies, and research on the connection between alcohol use and HIV and other medical and psychiatric comorbidities.